Next-generation sequencing-based neutralization assays to forecast influenza virus clade growth.

Project Summary/Abstract
Every year, seasonal inﬂuenza viruses emerge with hemagglutinin (HA) surface protein mutations that confer
escape from previously-protective neutralizing antibodies. This process is known as antigenic drift, and it
necessitates frequent vaccine updates. Historically, the viral strains with the most antigenically drifted HA
variants tend to dominate a given inﬂuenza season. Previous work has taken advantage of this observation by
training forecasting models on antigenic data (e.g., titers from neutralization or hemagglutination-inhibition
assays) in addition to genomic and epidemiologic data. However, these assays are low in throughput and
scope, and generally only completed for a limited number of strains. Nevertheless, incorporating antigenic
measurements for even partial circulating variant diversity in forecasting models has improved their accuracy.
Development of methods that could generate more comprehensive datasets – that is, measuring the
neutralizing titers of all circulating HA diversity – is therefore an a ractive goal.
Here, I propose the development and an application of a next-generation sequencing-based
neutralization assay that would parallelize antigenic measurements of ~100 currently circulating pdmH1N1
and H3N2 inﬂuenza A viruses in high-throughput. In this approach, inﬂuenza viral variants are selected,
barcoded and pooled to create a multiplexed virus library. This library will then be used to simultaneously
measure neutralizing titers for all viruses against a given serum specimen. Current approaches frequently rely
on ferret sera, which do not fully represent the complexities of epitope targeting exhibited by human sera. I
propose using this method to proﬁle serum from several diﬀerent human cohorts. The proposed cohorts were
selected to more adequately represent the heterogenous immune responses comprising population immunity
as a whole. Using this dataset, I will then test the hypothesis that more comprehensive antigenic
measurements will improve the ability to forecast inﬂuenza variant success. I will assess the predictive power
of these measurements both on their own as well as incorporated into previously established ﬁtness models.
Overall, I will develop a method to parallelize neutralization assays with ~100 currently circulating
inﬂuenza A viruses. I will then use computational methods to ask if these measurements improve our ability to
predict inﬂuenza strain dominance for a given season. Importantly, a major goal of vaccine strain updates is
that the vaccine strain matches the seasonally dominant variant(s). The approach set forth in this proposal
therefore has the potential to improve our ability to select vaccine strains.

Public health relevance
Project Narrative Seasonal inﬂuenza A viruses readily acquire mutations in the surface hemagglutinin protein. The viral variants that contain hemagglutinin mutations that confer escape from previously established population immunity tend to dominate a given inﬂuenza season. I am developing an assay to measure the neutralizing titers of human sera against many inﬂuenza viruses simultaneously, thereby comprehensively proﬁling the antigenic variability of currently circulating inﬂuenza strains.